Encoding of fear and safety discrimination in prefrontal-amygdala projections

Project Summary/Abstract
This proposal is for a four-year research career development program, focused on the study of the
neurophysiology of fear and safety discrimination, which has relevance to anxiety disorders and post-traumatic
stress disorder. By the start of the project, the candidate will have been appointed an Instructor in the
Department of Psychiatry at Weill Cornell Medical Center. The proposal is a natural extension of the
candidate's previous research and clinical training on safety signals in the medial prefrontal cortex (mPFC) and
basolateral amygdala (BLA). It outlines a plan for the candidate to achieve his goal of becoming an expert in
the circuit mechanisms of fear and anxiety disorders, extending the training of the candidate in two dimensions,
which are reflected in the mentorship of Drs. Conor Liston and Joshua Levitz: 1. Encoding of fear and safety-
related information in large, distributed mPFC and BLA ensembles and 2. Cell-surface receptors that modulate
prefrontal output to the BLA for successful fear discrimination and represent promising pharmacological targets
for treating generalized fear. The proposed experiments and multi-faceted training plan will impart the
candidate with a unique combination of skills that will position him to transition into a successful independent
career as a physician-scientist studying the neurophysiology of fear and anxiety in psychiatric disorders.
Anxiety disorders are the most prevalent mental disorders, affecting one-fifth to one-third of the adult US
population, and the disorders are typically chronic, associated with high disease burden and significant
healthcare cost. While effective treatments exist, a substantial proportion of patients are minimally responsive,
underpinning the need to develop therapeutics that work through different cellular mechanisms. Anxiety
disorders are highly co-morbid with each other and with other psychiatric disorders, highlighting the value of
research into common neurocircuit mechanisms with trans-diagnostic relevance. Patients with PTSD or anxiety
disorders have both been found to exhibit the overgeneralization of conditioned fear, which is associated with
abnormal reactivity of the mPFC and BLA. The goal of my proposal is to investigate the encoding of fear and
safety discrimination in interconnected mPFC and BLA neurons. Specifically, this proposal investigates the role
of metabotropic glutamate receptor 2 (mGluR2) in controlling mPFC-to-BLA output by: 1. Defining high-
dimensional fear and safety encoding mechanisms in mGluR2+ and mGluR2- mPFC-BLA projectors; 2.
Elucidating fear discrimination learning-related changes in connectivity between mGluR2+ and mGluR2- mPFC
cells and functionally-distinct downstream BLA ensembles; 3. Dissecting the role of mGluR2 signaling
specifically at mPFC-BLA presynaptic terminals in fear discrimination learning. Collectively, these experiments
provide novel insight into the neurophysiology of fear and safety discrimination in the mPFC-BLA circuit and
investigate mGluR2 as a potential therapeutic target for anxiety disorders and PTSD.

Public health relevance
Project Narrative Fear is an essential adaptive mechanism for interacting with a changing environment, but fear can be maladaptive when it overgeneralizes, leading to distressing and intrusive defensive reactions in objectively safe situations. This is a common feature in anxiety and trauma-related disorders, for which current treatments provide at most minimal symptom relief in a third of affected patients. This research proposal will identify the neural circuit activity underlying fear discrimination, with the long-term goal of advancing the development of new treatments for anxiety and trauma-related disorders.